Justice Community Opioid Innovation Network (JCOIN): TCU Clinical Research Center

Project Summary/Abstract
The aims of the Parent Grant are to (1) Increase access to (referral rate increase) and retention in
(appointments kept) in appropriate community behavioral health and medical services for reentering criminal
legal system involved individuals who use or are at risk for using opioids, (2) Improve outcomes associated
with public health (decreases in days and amount of illicit drug use, including opioids) and public safety (e.g.,
reductions in rearrest rates), (3) Compare 2 implementation approaches on systems-level outcomes designed
to increase service initiation and receipt with respect to implementation (e.g., costs, attitudes of acceptability)
and service outcomes (e.g., referral rates), and (4) Examine the relative impact of these two approaches on
criminal legal system involved individual outcomes (e.g., services linkage, initiation and receipt, opioid use,
other substance use, overdose, death, rearrest). Based on our proposed study, we will be able to identify
which implementation strategy is most effective for rapid uptake and sustained use of EBPs based on the
Opioid Treatment Linkage Model. The specific aims of the Administrative Supplement are to (1) Measure the
prevalence rates of multilevel stigmas among correctional staff and clients. (2) Examine the impact of
multilevel stigma on cascade of care and public health outcomes among clients reentering society,
and (3) examine the impact of multilevel stigma on public safety outcomes among clients reentering
society.

Public health relevance
Project Narrative This study seeks to investigate how multilevel stigma impacts cascade of care, substance use and public safety (rearrests) outcomes among clients at risk of OUD who are reentering society. This supplement will assess multilevel stigma by implementing and adapting existing measures of public, internalized, anticipated, and enacted stigmas across multiple time points. The ultimate goal is to improve opioid-related outcomes for criminal legal system involved individuals reentering the community who have a history of (or are at risk for) opioid use.